RFA-IP-20-001 Psychomotor and cognitive development problems in a cohort of children after respiratory infection during pregnancy and/or early childhood

Abstract
A previous study titled Influenza Incidence, Diagnosis, Treatment Efficacy, Vaccine
Effectiveness (INFLUMI-Award: 1U01IP000791-01), which was conducted between 2013
and 2018 in Panama and El Salvador, observed the impact of respiratory virus, mainly
influenza on a cohort of women (N=2565) and their children (N=1586). Thus, requiring
robust epidemiologic, clinical, and laboratory surveillance systems and research
infrastructure. As part of the children's evaluation, a Bayley's III test was conducted
(N=1088) to determine any cognitive, psychomotor, or language impairment. The present
project proposes to improve surveillance, reporting and epidemiological intelligence with
further follow-up of the children cohort up to eight (8) years of age. The overarching goal of
the proposed project is to further evaluate the prevalence of psychomotor, cognitive, and
behavioral development problems among children in the cohort. At start of the proposed
Project in November 2019, the children will be 3.5 years of age. We pretend to follow them
up for four years. This will be accomplished by building-on existing partnerships and previous
research; supporting the development, maintenance, and expansion of sentinel surveillance
sites in Panama and El Salvador and by evaluating the effect on neurocognitive development
of frequent and severe respiratory infections during pregnancy that might impact early
chilhood. Processes include contact of children and re-introduction into the system during the
first year. Subsequent years will include training and capacity building of influenza, influenza
preparedness, and other respiratory pathogen surveillance in the Americas.

Public health relevance
Relevance to Public Health The proposed project strengthens surveillance of respiratory illness and influenza by building-on existing infrastructure, Regional partnerships and networks, and research projects. The public health significance of this project is to understand the impact of influenza and other respiratory virus on the psychomotor, cognitive, and behavioral development of small children in a large cohort. Outbreak investigation will be deployed if necessary. The in-depth understanding of respiratory illness and influenza in pediatrics population offer tremendous public health implications with repercussions at international levels. The proposed project will help generate surveillance and research protocols and public policies. This information will be most useful for future research and to determine the impact of respiratory illness during pregnancy on the development of the offspring. We anticipate that frequent and severe cases of influenza and other respiratory viral infections, during pregnancy and early life affect neurocognitive, psychomotor, and behavioral development in infants, this will assist clinicians and researchers in the following manner: a. Prevention of influenza would be more proactive. b. The innovative study will provide results that can be used and replicated globally. c. Influenza vaccination during pregnancy will be promoted more actively. Another important contribution of the study is the analysis of demographic, social, and cultural factors that impact the onset of respiratory illnesses during pregnancy. As well as the use of the Bayley's III Test to evaluate the impact of cognitive, psychomotor, and language development. And, finally the innovative inclusion of behavioral analysis in the participants' follow-up will contribute immensely to universal knowledge and applied to public health policies and interventions. The study will provide enormous contributions to public health. The results will generate the tools and necessary information to promote influenza vaccination among pregnant women. This is a segment of the population, where vaccination was been low in many countries. If the results of the study prove positive to prevent influenza and furthermore the impact in their offspring development, this will generate compelling information to promote and educate the population at large and health care providers on the importance of vaccination against influenza and prevention of respiratory illness during pregnancy.